Location-specific In Vivo Sensing and Imaging of Butyrate in the GI Tract

Project Summary
The short chain fatty acid butyrate is a key molecule in the human gut metabolome,
regulating bacterial growth, inflammation, and colon cell health. Despite its importance
there is currently no reliable method for inline monitoring of butyrate production in situ.
In addition, cecal and fecal levels of butyrate are often not good predictors of butyrate
production by gut bacteria. The goal of this proposal is to build bacterial biosensors for
butyrate which, coupled to cellular memory circuits, will enable monitoring of butyrate
content throughout the small and large intestine and biogeographical mapping of
butyrate concentrations. This technology will allow researchers to test many different
interventions (e.g., prebiotics, probiotics, and other forms of butyrate supplementation)
with the goal of optimizing the levels of butyrate in the gut. We will also test
interventions that increase butyrate as a proof of concept of the method.

Public health relevance
Project Narrative The goal of this proposal is to establish techniques that lead to location-specific quantification of the important short-chain fatty acid butyrate in the gut. This molecule is difficult to quantify but is important to many different disease states. Therefore, there is great need to rapidly track its production in the body and determine the effectiveness of interventions to change butyrate concentration such as prebiotics and probiotics.